Development of dual Soluble Epoxide Hydrolase/Fatty Acid Amide Hydrolase Inhibitors as a Promising Therapeutic Strategy for the Treatment of Acute and Chronic Pain

Project Summary/Abstract
We aim to develop dual soluble epoxide hydrolase/fatty acid amide hydrolase inhibitors that will be used
as a promising novel therapeutic strategy in the pain management. We will study a series of benzothiazole-
phenyl piperidine analogs which exhibit potent inhibition at both targeted enzymes, and that are metabolically
stable in liver microsomes. The compounds we propose to study represent a much-needed, completely novel,
nonopioid, starting point in pain management research. Because this class has different biological targets from
existing analgesics, it represents an opportunity to solve long-standing problems that have been linked to the
existing therapies in pain management. In this project we propose that the simultaneous regulation of the two
enzymes, soluble epoxide hydrolase (sEH) and fatty acid amide hydrolase (FAAH), by dual inhibitors, can be
expected to play a significant role in the success of this therapeutic strategy. We know that co-administration of
sEH and FAAH inhibitors significantly reduces pain in several animal models of pain. However, this promising
strategy of dual inhibitors of both enzymes has not been robustly investigated as a nonopioid pain medication
development approach. This novel class of nonopioid analgesics provides flexibility and an advance in the
medicinal chemistry space that may overcome weaknesses in the currently available pain treatments. The most
original and mechanistically distinct aspect of these compounds is their ability to simultaneously inhibit two
different enzymes that play significant roles in pain and inflammation. Overall, the combination of structure-
activity relationship studies and computational approaches in this proposal will enable a detailed characterization
of the molecular determinants required for dual inhibition of these novel ligands. This will ultimately allow the
development of potent and metabolically stable dual sEH/FAAH inhibitors. Such molecules will be valuable to
study as pain management therapeutics with predictably superior clinical profiles as compared to current opioid
and nonopioid drugs.

Public health relevance
Project Narrative The proposed research focuses on in silico and structure-activity relationship studies, and optimization of novel dual soluble epoxide hydrolase/fatty acid amide hydrolase inhibitors. These small molecules are designed to increase the levels of anti-inflammatory metabolites, epoxyeicosatrienoic acids, and antinociceptive endocannabinoids by inhibiting the aforementioned enzymes responsible for their metabolism and degradation. Through in vitro studies we propose, we will show that the designed dual inhibitors are effectively and simultaneously inhibiting both enzymes, are metabolically stable and have the potential to become new treatments for acute and chronic pain.